Development of Layer Specific FMRI for Clinical Scanners

Summary
Layer Specific FMRI is a new and exciting tool to probe mesoscale brain networks non-invasively,
without the need for invasive surgical procedures, such as electrode implantation, or confocal
microscopy. Recent work has demonstrated the Layer Specific FMRI can identify both the
columnar, as well as layer specific structure of a network. While the field of Layer Specific FMRI
is dominated by “ultra-high” field MRI scanners (7T and above), it is still extremely challenging
to achieve those results in 3T scanners because of their reduced signal:noise ratio (SNR). The
need for ultra-high field scanners stems from the requirement of extremely small voxels for layer
specific FMRI, which translates into a dramatic loss of SNR.
This need for ultra high field scanners means that much of it has to be carried out on small
animals, and human work in this area is limited to a few select institutions. The goal of this
proposal is to develop the technology needed to make layer specific FMRI feasible at 3T scanners,
common in most research institutions. Our proposed strategy is to improve SNR efficiency and
reduce scan time by using a reduced field of view, 3D read-out in tandem with a new positive
vascular contrast imaging method based on Velocity Selective pulses to collect arterial blood
volume weighted images much faster. At the same time, we will also aim to reduce the noise of
the measurement by an efficient echo correction technique.

Public health relevance
Public Health Statement Recent developments in FMRI using “ultra-high” field MRI scanners (7T and above) allow for resolution of brain activation with much finer detail and specificity than the state of the art FMRI. The goal of this proposal is to develop the technology needed to make layer specific FMRI feasible at common 3T scanners, common in most research institutions. If successful, we expect this technology to fill the translational gap between animal and human work, and to boost the capabilities of clinical neuroscience and psychiatry.